Investigating the Impact of Disease-Associated Mutations on DNA Methyltransferase 1 Function

Project Summary
In humans, the most common epigenetic DNA modification is methylation of cytosines, predominantly in CpG
dinucleotides. Disruption of the normal DNA methylation pattern is known to play a role in several diseases.
DNA methyltransferase 1 (DNMT1) is primarily responsible for maintenance of the DNA methylation pattern
through multiple rounds of cell division. DNMT1 is a multidomain protein with a C-terminal catalytic
methyltransferase domain and a large N-terminal regulatory region. The Replication Focus Targeting
Sequence (RFTS) domain, found in the N-terminal regulatory region, is a key regulator of DNMT1 activity in
vivo. The RFTS domain binds to the DNA binding site and prevents association with DNA. In addition, the
RFTS domain is involved in several protein-protein interactions that serve to localize and activate DNMT1 for
catalysis. Recently, mutations in the RFTS domain have been identified that result in two different adult onset
neurodegenerative disorders. Affected individuals exhibit modified DNA methylation patterns with global
hypomethylation and site-specific hypermethylation. The molecular mechanisms that lead to this altered
methylation pattern are still unclear and little is known about the biochemical consequences of these
mutations. In this proposal, we seek to understand how these changes in amino acid sequence are impacting
the structure and function of DNMT1. For specific aim 1, melting temperatures and fluorescence anisotropy will
be used to examine changes in protein stability and dynamics induced by the disease-associated mutations.
For specific aim 2, RFTS-mediated autoinhibition will be assessed in the mutant enzymes. Both DNA binding
affinity and DNA methylation activity will be examined in wild-type and mutant enzymes to determine if the
mutations relieve normal autoinhibition. For specific aim 3, the impact of the mutations on key intermolecular
interactions will be examined. The RFTS domain is known to bind to UHRF1 (ubiquitin-like, containing PHD
and RING finger domains protein 1) and modified histone H3 tails. Isothermal titration calorimetry will be used
to investigate the impact of RFTS mutations on these regulatory protein-protein interactions. Our preliminary
work shows that disease-associated mutations G589A and V590F reduce thermal stability of the protein while
also increasing DNA binding affinity and catalytic activity, indicating at least partial relief of normal RFTS-
mediated autoinhibition in these mutant enzymes. Collectively, these studies represent an excellent training
opportunity for undergraduate students. Undergraduates will engage in all aspects of this research and gain
hands-on experience designing experiments, collecting and analyzing data, and interpreting results. We expect
our biochemical studies to yield key insights into the consequences of the disease-associated mutations that
will ultimately aid in our understanding of the molecular mechanisms of disease formation in affected
individuals.

Public health relevance
Project Narrative Methylation of cytosines in our DNA is an important way our cells control when a gene is expressed and proper methylation patterns are essential for normal cellular function. Mutations to the gene that encodes DNA methyltransferase 1, a key enzyme involved in methylation, have been linked to neurodegenerative disorders in humans. This project aims to uncover the impact of these disease-associated mutations on the function of the enzyme to gain a better understanding of how the diseases manifest in affected individuals.